OUTREACH

According to NCI's Strategic Plan, community-engaged research is vital for understanding cancer-related health disparifies and devising effective, culturally-appropriate strategies for reducing these disparities.^ In the first funding cycle (2001-2006), the MMC-VICC Cancer Partnership lacked a community outreach component and primarily focused on basic and clinical cancer research, with only one clinic-based behavioral research project. In 2006, the Partnership created a new Community Outreach Core (COC) guided by a framework of CBPR'*'^ to further the aims ofthe Cancer Partnership in reducing cancer disparities. Given its strong history of community-based research with minority communifies, TSU was brought in as a subcontractor to co-lead the new COC, under the leadership of Dr. Baqar Husaini (TSU), Dr. Elizabeth Williams (VICC) and Dr. Paul Juarez (MMC), and with Dr. Pamela Hull (TSU). In August 2010, Dr. Wujcik took over as VICC Co-Leader when Dr. Williams left VICC to join the TSU public health faculty.